CNS sites involved in the cardiovascular and renal effects of nociceptin in rats with heart failure

In vivo studies in conscious animals indicate that ORL1, for opioid receptor-like one,
receptor agonists produce profound changes in the cardiovascular function and renal excretion
of water and sodium via an action within the central nervous system (CNS). These observations
provide evidence to suggest that central endogenous ORL1 receptors participate in the regulation
of cardiovascular and renal function under normal and certain pathophysiological conditions. In
regard to endogenous systems, opioid peptides have been categorized into three major families,
β-endorphins, enkephalins and dynorphins, and are suggested to be the endogenous ligands for
the mu-, delta- and kappa-opioid receptors, respectively. In addition to these subtypes, a fourth
opioid receptor termed ORL1 has been identified. The endogenous ligand for the ORL1 receptor
has been isolated and is a novel endogenous peptide referred to as nociceptin (N/OFQ). Despite
their structural resemblance to endogenous opioid peptides and receptors, the role of nociceptin
and the ORL1 receptor in pathophysiological (e.g., heart failure) regulatory processes including
the regulation of cardiovascular and renal function, is not known.
Activation of ORL1 receptors in conscious healthy rats produce bradycardia, hypotension,
and a free water diuresis (increase in excretory urine flow rate without concurrent increase in
sodium excretion). In addition, this diuretic effect occurs without the loss of potassium. As such,
nociceptin produces pharmacological effects that are similar to the combined effect of several
drugs currently used to treat heart failure (e.g., ACE inhibitors, beta blockers, and diuretics). Thus,
nociceptin is a potential candidate for the treatment of this disease. However, the sites,
mechanism and pathways involved in these responses are unknown. Furthermore, the effects of
nociceptin in a heart failure model are still to be established.
Proposed experiments are designed to examine the changes produced by selective
activation of ORL1 receptors in a heart failure model. The results of these studies will provide
fundamental knowledge of how an individual component of the opioid system affects
cardiovascular and renal function. This is of importance because the development of novel
therapeutics with affinity for a specific opioid receptor subtype will require further investigation
under different experimental and pathophysiological conditions.

Public health relevance
Relevance Heart failure is characterized by increases in sympathetic nerve activity, plasma angiotensin II, and chronic extracellular fluid accumulation. Therefore, further understanding of different mechanisms and novel drugs that can either contribute to or oppose this disease is crucial from the perspective of disease diagnostics and the development of new therapeutic strategies.